The cap epitranscriptome: Regulation of mRNA fate and function by cap-associated methyl modifications

SUMMARY: It is now clear that the “epitranscriptome,” i.e., the pattern and distribution of regulated nucleotide
modifications in mRNA, is dynamic and has functional roles in the brain. We had a founding role in this field by
developing the technology for transcriptome-wide mapping of N6-methyladenosine (m6A), which allowed us
and others to reveal the transcriptome-wide dynamics of m6A in diverse tissues, signaling and disease
contexts. Although m6A is widely studied, it is only one of five abundant methyl modifications that were
discovered in mRNA in the 1970's. The other four are part of the “extended cap structure,” i.e. the cluster of
modified nucleotides at the 5' end of mRNA. These are the methyl on the m7G cap, 2'-O-methyl modifications
on the ribose of the first and sometimes the second transcribed nucleotides in mRNA, called Cap 1 and Cap 2,
respectively. Lastly, if the first transcribed nucleotide of an mRNA is adenosine, it can be methylated one more
time after ribose 2'-O-methylation to form dimethyladenosine: N6,2'-O-dimethyladenosine (m6Am). Of these,
levels of m6Am and Cap 2 vary between tissues and show evidence for regulation. Nevertheless, little is
known about how these dynamic changes in these modifications affects mRNA fates in neurons. In order to
uncover their function, we have identified the enzyme that synthesizes m6Am, identified the first m6Am reader
and developed a method for mapping Cap 2 throughout the transcriptome. In order to significantly advance
our understanding of the dynamics and function of the cap epitranscriptome in neurons, the specific aims of
this proposal are: (1) To uncover the mechanism for m6Am dynamics in neural stem cell differentiation.
The basis for the dynamic regulation of m6Am is unknown. To understand which mRNAs exhibit dynamic and
regulated levels of m6Am, we will use our transcriptome-wide m6Am mapping technique to generate maps of
m6Am in different brain regions. We will determine the principles that guide m6Am formation and regulation,
and determine if these dynamics are important for neural stem cell differentiation. (2) To determine how
m6Am affects the translation and stability of neuronal mRNA. In this aim, we take advantage of our
discovery of PCIF1 as the m6Am-forming methyltransferase to uncover the effects of m6Am on translation and
mRNA stability. We will also characterize a putative m6Am reader, to identify a mechanism for how m6Am
alters neuronal mRNAs. (3) To decipher the dynamics and function of the Cap 2 epitranscriptome. We
will obtain the first maps of Cap 2 throughout the brain. Using the Cap 2 maps and depletion of the Cap2-
forming methyltransferase, we will determine if Cap 2 is associated with altered mRNA translation, stability, or
other aspects of RNA processing. Overall, these studies will allow us to map and determine the role of the
“cap epitranscriptome” in controlling mRNA fate and function in neurons. We expect that this work will
stimulate a new area of gene expression regulation research focusing on uncovering how information encoded
by methyl modifications in mRNA caps influences mRNA biology.

Public health relevance
PROJECT NARRATIVE Recent studies have shown that mRNA can be dynamically regulated by methyl modifications that influence the fate of mRNAs in cells. Although the majority of studies have focused on N6-methyladenosine (m6A), an “epitranscriptomic” mark found at internal sites in mRNAs, the majority of methyl marks in an mRNA occur at the mRNA cap structure. Here we propose to study the roles, function, and regulation of diverse methyl marks at mRNA caps, revealing potentially novel mechanisms by which mRNAs are regulated in the brain.